The role and regulation of mitochondrial localization in mature neurons.

PROJECT SUMMARY/ABSTRACT
Dynamic regulation of mitochondrial localization is vital for the various energy demands and homeostasis
maintenance of subcellular regions. Key components governing mitochondrial motility, dynamics, anchoring, and
quality control have been identified. However, little is known about the signaling mechanisms by which neurons
coordinate mitochondrial localization in the short and long term in response to environmental and physiological
stimuli. This proper regulation of mitochondrial localization is particularly important in neurons with unique and
elongated structures that lead to a fundamental problem of a mismatch between the mitochondrial biosynthesis
site (cell body) and the high-demanding site for mitochondrial function (axon and synapse). Growing evidence
indicates that an irregular mitochondrial localization to the axon and synapse is closely associated with many
neurological disorders, including Alzheimer's disease, nerve degeneration, and regeneration failure. This
proposal aims to elucidate how neurons regulate mitochondrial localization in two fundamental conditions
including age and injury. In addition, we propose to determine how the regulation of mitochondrial localization
affects the maintenance of neuronal function against injury and aging. This proposal is built based on recent in
vivo studies that adult neurons undergo progressively reduced mitochondrial movement. Our lab and others
have also revealed that injured neurons acutely change mitochondrial movement and localization, determining
axon regeneration ability. The underlying mechanisms by which neurons regulate mitochondrial localization in
aging and injury conditions remain poorly understood. Lack of this knowledge hinders the development of
therapeutic strategies for neurological diseases such as Alzheimer's disease and nerve injury that have been
associated with abnormal mitochondrial localization. We combine Caenorhabditis elegans genetics,
mitochondrial biology, innovative in vivo imaging, and laser axotomy to address these unmet needs. Our
preliminary data suggest that the DLK-1 MAPK signaling, a conserved pathway associated with synapse
development, axon regeneration, and progressive neurodegeneration in Alzheimer's disease model, could be a
novel regulator of mitochondrial localization in neurons. This proposal consists of three specific aims to answer
how neurons regulate mitochondrial localization in aging and injury conditions (Aim 1), what the role of
mitochondria in the recovery of the adult neurons after injury (Aim 2), and how the communication between
mitochondria and nucleus controls the DLK-1 signaling, thereby mitochondria function and axon regeneration
(Aim 3). We expect that our proposed experiments will achieve a new understanding of the mechanisms that
maintain the optimal function of the nervous system by regulating mitochondrial function in aging and injured
neurons. Also, our findings will provide better insight into novel therapeutic approaches to restoring neuronal
function after nerve injury.

Public health relevance
PROJECT NARRATIVE Our research focuses on elucidating how adult neurons control mitochondrial localization under aging and nerve injury conditions. Accurate regulation of mitochondrial localization is essential for maintaining neuronal function in response to age and injury. An improved understanding of the signaling mechanisms underlying the regulation of mitochondrial localization will suggest therapeutic strategies to improve axon regeneration of injured neurons and treat neurological diseases associated with mitochondrial abnormalities.